Genomic Analysis of the CALERIE Trial to Generate New Knowledge for Geroscience

SUMMARY
The graying global population makes interventions to extend healthy lifespan (healthspan) a public heath
priority. Therapies targeting basic biological processes of aging show proof-of-concept in animals: early-to-
midlife intervention can delay disease onset and prolong healthspan. But translating these geroprotective
therapies to humans faces the barrier that human clinical trials of midlife geroprotective therapy would
require decades of follow-up to measure healthspan extension. An alternative is a short-term accelerated
geroprotector trial that tests if geroprotective intervention can slow the rate of biological aging. Biological
aging is the gradual and progressive decline in system integrity that occurs with advancing chronological
age. This process is thought to be the root cause of increases in morbidity and disability in later life. New
research shows that biological aging can be measured in humans and that measures of biological aging
predict human healthspan. Geroprotective therapies that target basic biological processes of aging are
hypothesized to slow the rate of biological aging. But this has not been tested. Our study will test if the best-
established geroprotective intervention in animals, long-term caloric restriction, slows the rate of biological
aging in midlife humans, who are still young enough for age-related disease to be delayed or prevented.
We will conduct new assays of stored biospecimens from the National Institute on Aging's recently-
completed CALERIE Trial, which randomized 220 non-obese adults to 25% caloric restriction (CR, N=145)
or ad libitum normal diet (AL, N=75) for a period of 2 years. We have already shown that CR slows aging-
related deterioration in organ-system integrity. Now, we propose to extend this test to genomic measures of
biological aging. We will assay whole-genome DNA methylation (using Illumina chips) and gene expression
(using RNA sequencing) from blood samples collected at CALERIE baseline, and at 12-, and 24-month
follow-ups. We will use this 3-time-point repeated-measures multi-omics dataset to test (i) Does CR slows
the rate of biological aging as measured from DNA methylation? (ii) Does CR cause changes to gene
expression in the pathways known to mediate healthspan-extending effects of CR in animals, e.g. the
mTOR pathway? (iii) Do changes to DNA methylation and gene expression mediate effects of CR on organ
system functioning? We will share the multi-omics data we generate with the CALERIE Biorepository,
making the resource freely available to all interested researchers. The proposed project will generate new
knowledge about effects of caloric restriction on biological aging in humans and test proof of concept for an
accelerated geroprotector trial design that can speed translation of new age-delaying therapies from
animals to humans. Open data sharing through the CALERIE Biorepository will enable research beyond the
scope of this project to improve understanding of caloric restriction and advance the field of geroscience.

Public health relevance
NARRATIVE The proposed project will conduct new genomic assays of stored biospecimens from the now completed CALERIE Randomized Trial, the first ever randomized human trial of long-term caloric restriction, an intervention known to extend healthy lifespan in animals. We will use new genomic data to test if caloric restriction slows the rate of biological aging in humans, which would establish potential to increase healthy lifespan in humans. We will publicly share all data generated in this project through the CALERIE Biorepository. Overall the project will advance efforts to translate discoveries from basic research in aging biology to improve human health in aging.